County incarceration and substance use treatment need, availability, use, and outcomes

Substance use disorder (SUD) treatment availability and use remain low despite an ongoing drug overdose epidemic in the United States. In 2019, 19.3 million non-institutionalized adults met the criteria for SUD, but only 2.6 million received specialty treatment services. People referred to SUD treatment through the criminal legal system are less likely to receive services (e.g., medication for opioid use disorder) than those who self-refer to specialty treatment. As a result, the criminal legal system may contribute to differences in SUD treatment need, use and outcomes in the community. Substantial knowledge gaps remain about how the criminal legal system, specifically county-level incarceration, affects community-level SUD treatment need, availability, use, and related outcomes. These gaps are exacerbated by the siloing of healthcare delivery system and criminal legal system data. To fill these gaps, we will link comprehensive multi-level data from counties in all 50 states from 2004-2023. We will quantify how county jail and prison incarceration rates are associated with: (Aim 1) community SUD treatment need (drug-related mortality rate, drug-related emergency department visit rate, SUD prevalence); (Aim 2) SUD treatment availability (number and types of available treatment services); and (Aim 3) SUD treatment use (self-reported, admission rates) and treatment outcomes (completion, retention) across communities and individuals. We hypothesize that greater county incarceration is associated with greater SUD treatment need (and vice versa), lower treatment availability, smaller increases in treatment use, and worse treatment outcomes. We anticipate that these relationships will have important spatial dependencies. Our hypothesized pathways and research process are grounded in theory. Our team, led by an Early-Stage Investigator, has expertise in substance use epidemiology and treatment, criminology, criminal legal systems, health policy and health systems, population health, biostatistics, and spatial methods. We will apply this expertise to study the criminal legal system, focusing on modifiable reform targets that can perpetuate and worsen SUD treatment-related outcomes over time. Our study addresses NIDA’s Notice of Special Interest (NOT-DA-19-037) calling for multi-level health services research on SUD treatment. By leveraging multi-level data sources and engaging with stakeholders, this innovative R01 examines how multiple systems converge to affect community health. We will incorporate experts and people with lived experience in the research process. Our multi-pronged dissemination plan will ensure that findings reach target audiences and inform health policies and programs that improve community-based SUD treatment-related outcomes.

Public health relevance
People with substance use disorders (SUD) in the criminal legal system often cannot access SUD treatment–and those who do are less likely to receive medication–which can reinforce pathways that worsen community health. We will study the dynamics between the criminal legal system and community SUD treatment system to generate unprecedented cross-sector evidence of the spillover effects of county incarceration on community SUD treatment need, availability, use, and outcomes. With input from experts and people with lived experience, we will disseminate findings to inform health policies that can transform the criminal legal and SUD treatment systems to reduce SUD-related morbidity and mortality.